Development of New Antibiotics Against Multidrug-Resistant Staphylococcus aureus

Project Summary Antibacterial resistance is an increasingly serious threat to global public health. In recognition of this threat, the President’s Council of Advisors on Science and Technology (PCAST) has recently submitted a report to President Obama underscoring the urgency of ensuring “an effective arsenal of antibiotics that is continuously renewed.” Two pathogens recently identified by the CDC as major antibiotic resistance threats in the United States are methicillin-resistant Staphylococcus aureus (MRSA) and vancomycin-resistant S. aureus (VRSA). This proposal is premised on the hypothesis that developing new antibiotics with novel mechanisms of action will provide an innovative and effective therapy against MRSA and VRSA infections. The proposed project will develop drugs that act against a new antibacterial target (FtsZ, a protein essential for bacterial cell division) unexploited by any antibiotics in current clinical use. The proposal incorporates innovative solutions to problems of drug administration, elimination, and resistance that have hindered early efforts to develop drugs targeting bacterial cell division. Significantly, strong preliminary results are presented that provide validation for the innovative approach. The three areas to be investigated in this project are: 1. Identification of compounds that improve antibiotic efficacy. A problem associated with FtsZ-targeting compounds that have been generated to date is rapid elimination due to metabolism. This aim is geared toward the synthesis and evaluation of new compounds designed for resistance to metabolism and thus longer durations of action and enhanced efficacy in vivo. The studies in this aim will include assays to establish that our compounds are sparing of human gut microflora, as well as human and other mammalian cells. 2. Can other antibiotics function synergistically with our compounds? Synergistic combination therapy is an effective strategy for enhancing in vivo efficacy, while also minimizing the potential for toxicity and emergence of drug resistance. We hypothesize that our FtsZ-targeting compounds should act synergistically with drugs that target the penicillin binding proteins (PBPs), since both the PBPs and FtsZ play important roles in a common pathway leading to bacterial cell division. This aim is geared toward identifying PBP-targeting antibiotics that act synergistically in combination with our FtsZ-targeting compounds, while also reducing the frequency of resistance. 3. Selection of promising preclinical drug candidates. A critical step toward the selection of a preclinical candidate is a pharmacological safety assessment for potential toxicities. This aim is geared toward toxicological evaluation of our lead compounds with regard to genotoxicity (Ames mutagenicity), cardiotoxicity (hERG potassium channel inhibition), and single-dose acute toxicity. Together, these investigations will culminate in the selection of preclinical drug candidates primed for benchmarking Investigational New Drug (IND) studies. Ultimately, this will improve clinical practice by providing a new therapy for the treatment of multidrug-resistant (MDR) staphylococcal infections that will be effective even when current standard-of-care drugs fail.

Public health relevance
Project Narrative Antibacterial resistance is an increasingly serious threat to global public health. In recognition of this threat, the President’s Council of Advisors on Science and Technology (PCAST) has recently submitted a report to President Obama underscoring the urgency for the development of new antibiotics. The proposed project will develop new antibiotics that act against a novel bacterial target. Ultimately, the results of the proposed work will enable us to take a major step toward addressing the urgent need for new drugs to treat multidrug-resistant bacterial infections that will be effective even when current drugs fail.